Investigation of nanobubble nucleation by radiation therapy

Abstract
This project investigates a little-known physical property of ionizing radiation, which has the potential to increase
the therapeutic ratio of radiation therapy (RT). Several decades ago, it was observed that ionizing radiation could
nucleate gas nanobubbles (NBs) in water and other liquids. Seminal experiments revealed the presence of NB
in irradiated water, which manifested as a decrease in the ultrasound power required to achieve acoustic
cavitation. These results raise a crucial yet unanswered question: Does ionizing radiation nucleate NBs in vivo,
inside irradiated tissues? Radiation is widely used in medicine. The premise that NBs may be nucleated in
patients during diagnostic scans or radiation therapy is significant because NBs could induce biological effects.
In addition, their presence in the tissues may lower the threshold for acoustic cavitation, which suggest a novel
mechanism for increasing the efficacy of radiation therapy. The first Aim of this project is to gather rigorous and
comprehensive evidence of NB nucleation in irradiated cells in vitro. Sensitive assays, including darkfield
microscopy and ultrasound imaging, will be used to detect NBs in cells after exposure to ionizing radiation. This
study will generate quantitative estimates of the efficiency of NB nucleation for different types of radiation,
including their kinetics and stability under different conditions. The second Aim is to explore the use of radiation-
induced NB to enhance the therapeutic efficacy of RT. Given that exogenously administered NBs are already
used to increase the efficacy of high-intensity focused ultrasound (HIFU), intrinsically induced NBs nucleated
during exposure to ionizing radiation should have similar enhancing effect for HIFU. Therapeutic efficacy of this
combined treatment will be assessed by treating multicellular tumor spheroids sequentially with RT and HIFU,
then quantitatively assessing the biological response of the cells. The proposed combination uses treatment
modalities approved for use in humans and requires no extrinsic agents to be administered. This combination of
radiation-induced NB nucleation and ultrasound-driven NB cavitation is a highly innovative and practical solution
to the issue of treatment-resistant tumors.

Public health relevance
Narrative Radiation therapy has many benefits that explain its widespread use, but its curative potential is limited by the induction of toxicity in the tissues surrounding the tumor. This project aims to improve the efficacy of radiation therapy by combining it with high-intensity focused ultrasound. The hypothesis underpinning this scheme is that ionizing radiation nucleates nanosized gas bubbles, which would enhance cell killing through ultrasound cavitation effects.